Core-Vision Processes: Administration Core

ADMINISTRATIVE CORE: Project Summary
The Administrative Core ensures the three service Cores (Machine Core, Electronics Core and
Imaging Core) are efficiently run, coordinated, communicated, and evolved as needed to meet the
overall goals of the NEI Core grant. Most importantly, the Administrative Core supervises,
mentors, and administratively supports the personnel in the service Cores to keep the Core
personnel working toward the specific aims of each of the service Cores and provides
opportunities for additional training of those personnel as needed for those aims. The
Administrative Core ensures the availability and equitable use of the service Cores and develops
and deploys software to assist in this effort. The Administrative Core upholds a culture of
transparency and collaboration by communicating the ever-evolving Core services to keep all
investigators up to date with the technologies and capabilities of each Core, communicating the
projects in the service Cores, and facilitating dissemination of designs and know how. Finally, the
Administrative Core tracks changes in research needs of the Core NEI Investigators and adapts
the Cores to meet those ever-evolving needs. Because these efforts keep the Cores focused on
their overall mission, all of the proposed activities were previously performed on an ad hoc
basis. However, the formal addition of the Administrative Core in this renewal application will
enhance these activities and thus enhance the impact of the overall Core.